CS-622 DURATION OF ACTION IN MILD TO MODERATE ESSENTIAL HYPERTENSION

The purpose of this study was to assess the safety, tolerability, and duration of action of the investigational angiotensin converting enzyme inhibitor, CS-622, in patients with mild to moderate essential hypertension. This was a double-blind, placebo controlled, ascending dose, parallel study with an initial single-blind placebo period.